PHASE III COBRE IN VASCULAR BIOLOGY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The COBRE in Vascular Biology was established in 2000 with the goal of understanding the mechanisms of vascular remodeling and disease. In the past two funding periods of COBRE support, we have built a successful center of collaborative, independent cardiovascular biology researchers. Integral to our scientific progress was the establishment of institutional core facilities in areas critical to support success of our research program. The core facilities described in this application have developed into widely used institutional and regional resources that have increased scientific collaboration, the quality and impact of our research, and thus the competitiveness of our investigators. This Phase III COBRE application for transitional support aims to further enhance four existing core facilities towards self-sustainability, while additionally providing pilot project support to foster collaborative research using state-of-the-art strategies. The successes of this COBRE in Phases I-II included the assembly of a highly collaborative team of investigators focused on inter-related themes in vascular biology, achievement of independent extramural funding for each investigator, development of a mentoring program with input from both internal and external advisors, and the development of significant research infrastructure to support the goals of all research programs at Maine Medical Center Research Institute (MMCRl). The specific aims of this application are: 1) to maintain mentorship and training of all Center investigators, trainees, and staff, 2) to promote a collegial, intellectually stimulating environment that fosters scientific excellence, 3) to maintain the Center at the cutting edge of vascular research through infrastructure improvements, advanced training, and financial sustainability, and 4) to stimulate collaborations and enhance grant funding opportunities through a pilot project program. These aims will continue to advance this program towards national prominence by maintaining state-of-the art research technologies and expertise, and toward self-sufficiency through collaborative multi-investigator and program grants. Our biomedical research programs also contribute to the NIH mission to improve the nation's health, with our focus on understanding mechanisms of disease.